Elucidating the role of somatic 3’UTR mutations in prostate cancer pathogenesis

PROJECT SUMMARY
Prostate cancer is the second most common cause of cancer mortality in US men due to our poor understanding
and treatment of metastatic, castration-resistant prostate cancer (mCRPC). New insights into mechanisms of
prostate cancer pathogenesis may be found within historically understudied aspects of gene expression,
including post-transcriptional regulation of oncogenes. An important mediator of post-transcriptional gene
regulation is the 3’ untranslated region (3’UTR), which plays critical roles in controlling mRNA stability and
translation. The 3’UTR harbors a significant mutational burden across cancer patients; however, these mutations
have not been extensively studied. Individual 3’UTR variants have been associated with cancer risk and shown
to regulate expression in reporter assays, but it is still unclear whether these mutations significantly affect
pathogenesis in patients and how widespread this dysregulation may be across cancer. By performing somatic
mutation calling on a unique cohort of 230 prostate cancer patients, I have uncovered over 13,000 3’UTR somatic
mutations in cancer tissues genome-wide. Many of these are in known cancer-related genes and 3’UTR
regulatory motifs, indicating they have potential to affect oncogenic expression and cancer pathogenesis.
Furthermore, I have determined via ribosome profiling of a subset of patient samples that ~40% of 3’UTR
mutations are associated with changes in post-transcriptional gene regulation. Using individual reporter assays,
I have validated that several of these patient-identified 3’UTR mutations in known cancer-related genes
significantly alter gene expression. One of these functional mutations is in PAK2, a p21-activated kinase involved
in cell motility, hyperactivation of which is oncogenic in several cancers. Based on these preliminary data, I
hypothesize that 3’UTR mutations drive oncogenic changes in post-transcriptional gene regulation, such as
overexpression of PAK2, that contribute to pathogenesis in prostate cancer patients. I now aim to define the
molecular and pathogenic mechanisms by which this PAK2 3’UTR mutation increases PAK2 expression and
exacerbates cancerous phenotypes in vitro and in vivo using an endogenous cell line model of the mutation.
Additionally, I will investigate the extent of 3’UTR mutation-mediated gene dysregulation in cancer by performing
a massively-parallel reporter assay to determine the effects of >6,000 patient-identified 3’UTR mutations on
transcript levels and translation efficiency. These studies will establish 3’UTR mutations as important drivers of
oncogenic dysregulation, expanding the field of functional cancer genomics and our understanding of prostate
cancer pathogenesis, in addition to potentially identifying new therapeutic targets.

Public health relevance
PROJECT NARRATIVE Research into historically understudied areas of gene regulation, including the 3’ untranslated region (3’UTR), a critical genomic region mediating post-transcriptional gene regulation, will fill gaps in our current understanding of prostate cancer and lead to uncovering new mechanisms of disease, therapeutic targets, and treatments. I have found that 3’UTR somatic mutations, which occur at similar rates to protein coding-sequence mutations in prostate cancer patients, can significantly alter oncogenic post-transcriptional gene expression and are associated with poor prognosis in patients. In this proposal, I will uncover how 3’UTR mutations found in prostate cancer patients change oncogenic gene expression and thereby contribute to pathogenesis, both mechanistically for a specific likely oncogenic mutation in PAK2 and broadly for thousands of mutations found genome-wide across patients.